Core B: Biospecimen Core

CORE B – BIOSPECIMEN CORE: PROJECT SUMMARY
The Biospecimen Core (Core B) is the cornerstone of all Yale SPORE in Skin Cancer (YSPORE) activities. It
addresses the broad melanoma patient specimen needs of all the projects that are not met by current shared
facilities at Yale. In addition to collecting, storing and distributing a wide range of specimens and reagents, the
core performs quality assurance testing and a wide range of molecular analyses of specimens. More specifically,
the core: a) collects a large repertoire of specimens for translational and preclinical studies in melanoma,
including melanocytic lesions, melanoma tumors and cells, normal skin, serum, and circulating lymphocytes;
b) ensures high quality control, proper long-term storage, detailed annotation, and timely distribution of
specimens to YSPORE investigators; c) establishes and maintains a central database of essential pathological,
clinical, epidemiological, and follow-up information and basic research data generated by the YSPORE projects
that is integrated with the Biostatistics and Bioinformatics Core; d) provides special services such as the analysis
of specimens from clinical trials, mutations, chromatin modification, and collection of TIL (tumor infiltrating
lymphocytes); e) maintains and distributes validated reagents (antibodies, oligonucleotides for PCR, DNA, RNA,
plasmids, cell extracts) needed for molecular analyses of tumors by different YSPORE investigators;
f) establishes links with shared facilities at Yale and similar resources in other institutions, including other
SPOREs; g) distributes samples to collaborating investigators outside of Yale; and h) provides specimens for
larger NCI objectives, such as melanoma specimens, peripheral blood lymphocytes, and annotated clinical data
for The Cancer Genome Atlas (TCGA). The core interacts extensively with investigators in each project, the
Bioinformatics and Biostatistics Core, the Clinical Trial Office, and Yale Cancer Center shared resource cores
such as Yale Pathology Tissue Services and Yale Center for Genome Analysis. The services of the Biospecimen
Resource Core enhance the efficient operation of the translational studies by YSPORE investigators in a cost-
effective manner, and expedite the application of discoveries from the bench to clinical practice, and clinical
results to basic research.

Public health relevance
CORE B – BIOSPECIMEN CORE: PROJECT NARRATIVE Biospecimen Core (Core B), provides a variety of clinically annotated samples (tumor, normal skin, plasma, peripheral blood lymphocytes, tumor infiltrating lymphocytes, serum, short term cultures, DNA and RNA) to SPORE investigators and other collaborators at Yale and outside of Yale. Integration with Core C for storage of data is key to maximizing utilization of specimens and distribution of samples is governed by a Tissue Committee. The Core is central to all the activities of YSPORE and well integrated with pathology and clinical services at Yale Cancer Center.